Effect Of Diet and Other Early Exposures on Child Health and Development

Diet and other early exposures may affect child development and the risk of several chronic diseases, but additional research is needed. The current research described in this catch-all project comprises two project, described below A workshop report presents state-of-the-art assessment of endocrine disruption in neonates. We also conducted a study of determinants of age at menarche among young women in the Collaborative Perinatal Project. The main finding was that, in contrast with a previous study, that exposure to cigarette smoke in utero was unrelated to subsequent age at menarche. Two other projects on which I collaborated were lead by Dr. Donna Baird of the NIEHS Epidemiology Branch and are described in her report. Last years progress: 5 papers were published (see list below).